Integrative framework for surface protein imputation for spatial biology of cancer

Project Summary
Tumors are not only aggregates of malignant cells but also well‑organized complex ecosystems. Spatial
organization is strongly related to tumor development, recurrence, metastasis and treatment response. Spatial
transcriptomics (ST) technologies measure genome-wide mRNA expression across thousands of spots on a
tissue slice while preserving information about the location of spots and delineating these complex tumor
ecosystems. Recent technological advances allow simultaneous profiling of genome-wide gene expression
and multiplexed surface protein expression with histopathological evaluation (“spatial CITE-seq”). Surface
proteins are integral markers of specific cellular functions indicating cell states and serve as primary targets for
therapeutic intervention. There is growing number of spatial transcriptomics data without surface protein
measurements. Although machine learning (ML) approaches for cross-data imputation —predicting missing or
unobserved data based on available information— exist, they have not specifically applied to transfer
knowledge from spatial CITE-seq to ST for protein imputation. The goal of the project is to increase utility of
spatial transcriptomics datasets by imputing surface protein abundance through incorporation of spatial and/or
histological dependencies and simultaneously learning the RNA–protein mapping relation from spatial CITE-
seq. Imputing surface protein expression from spatial transcriptomics data is significant because it enhances
our understanding of tumor biology and cellular interactions within spatial domains. Surface proteins are vital
for cell signaling and communication in the tumor microenvironment, and their accurate imputation allows
researchers to bridge the gap between gene expression and protein function. This process facilitates the
discovery of biomarkers for diagnosis and prognosis, informs targeted therapeutic strategies, and provides
insights into how tumors evade immune detection. Our methods will be integrated into software packages for
wide accessibility, and we will apply our computational framework to publicly available ST datasets to predict
protein abundances. Web resources will feature a user-friendly interface for systematic data visualization,
search, and download, and an interactive web application will be developed to allow researchers to input their
own ST datasets and use pre-trained models to predict protein abundance. Our work addresses a crucial gap
in analysis methods for spatial transcriptomics data and paves the way to better delineate tumor immune
microenvironment for cancer research.

Public health relevance
Project Narrative The environment surrounding tumors, known as the tumor microenvironment (TME), influences how cancer develops and responds to treatment. Cutting-edge technologies that focus on the spatial aspects of tumor biology now provide us with an abundance of multi-modal data. Our goal is to develop computational methods to better transfer knowledge to existing data from these multi-modal data for cancer research.